Administrative Core

The Administrative Core (Core A) will execute the administrative needs of the NYU Langone Health Metastasis
Research Network (NYULH MetNet) Center investigators and collaborators, optimize the utilization of resources
available to the projects, and synergize the intellectual depth of NYULH investigators to achieve the research
goals of the NCI’s Metastasis Research Network. The four overarching goals of the Administrative Core include
NYULH MetNet Center governance, intra-programmatic and inter-programmatic communication oversight,
financial and scientific reporting management, and conscientious public outreach.
Specifically, the Admin Core aims to: 1) Provide strategic planning for the execution of the NYULH MetNet
Center’s research goals, administrative support for full research and pilot projects, and policies to continuously
monitor all Center activities. 2) Develop a review and award process for pilot projects that encourages junior
investigators to conduct metastasis research. 3) Establish and maintain policies for prudent financial
management and maximize efficient resource use and sharing by leveraging administrative and scientific
infrastructures of the NYU Melanoma SPORE and NYU Perlmutter Cancer Center (PCC) across all MetNet
Center activities for cost-effectiveness, quality assurance, and Center integration. 4) Fulfill the NYULH MetNet
Center governance responsibilities, including regulatory compliance, fiscal oversight, and account management
of NYULH MetNet Center activities. 5) Augment our community outreach and engagement programs to integrate
a broad patient perspective. As the administrative nucleus for the NYULH MetNet Center, the Admin Core
leadership will organize intra-programmatic meetings as well as attend all Metastasis Research Network
meetings. The Admin Core, in accordance with federal and local governments, NIH, and institutional policies,
will manage the budgetary accounting of all Center activities. Finally, the Admin Core will be responsible for
sustaining communication and cooperation with the NYULH, PCC, and NCI/NIH administration, and overseeing
the timely submission of all required progress reports.

Public health relevance
Our research focuses on improving melanoma outcomes, by identifying novel drivers of metastasis, translating biomarker research into clinical applications. This research is relevant to public health because it aims to reduce the burden of melanoma-associated death by developing more effective therapies and improving early detection. By addressing these critical areas, the research has the potential to significantly improve the health and well-being of all melanoma patients.